A Novel Plasminogen Receptor Promotes Adipose Function and Metabolic Homeostasis

Project Summary
In 2016 more than 1.9 billion adults were overweight and, of these, over 650 million were obese. Rising
obesity rates have significant health consequences, contributing to increased rates of metabolic diseases
including type 2 diabetes, steatosis, hypertension, and heart disease. Associations between obesity, insulin
resistance and diabetes are complex, and how an increase in adiposity leads to metabolic and cardiovascular
complications remains a critical gap in knowledge. Our exciting preliminary data show that the novel
plasminogen receptor, Plg-RKT, is highly expressed in adipose tissue of lean mice and in response to a high fat
diet (HFD), adipose expression of Plg-RKT is dramatically reduced. Furthermore, HFD-fed Plg-RKT-/- mice gain
more weight, are more insulin resistant/glucose intolerant, and develop more hepatic steatosis than Plg-RKT+/+
littermates. These metabolic abnormalities are associated with increased adipose tissue macrophage
accumulation and inflammation, increased adipose fibrosis and decreased expression of markers of
adipogenesis. Furthermore, Plg-RKT expression is low in preadipocytes but dramatically increases during
adipogenesis; an expression pattern consistent with pathways that promote adipogenesis. Thus, surprisingly,
in addition to maintaining the anti-fibrotic, anti-inflammatory adipose environment, Plg-RKT coordinately
regulates multiple aspects of adipose function that are also important to maintain efficient adipocyte function
and metabolic homeostasis by directly promoting adipocyte adipogenesis and directly promoting adipocyte
insulin sensitivity. Our long term goal to understand mechanisms by which Plg-RKT regulates physiologic and
pathologic processes.! Our objective in this application is to determine mechanisms by which Plg-RKT
regulates adipose function and systemic metabolism, as unifying mechanisms that maintain healthy adipocytes
as well as limit chronic adipose inflammation and ectopic lipid deposition. The central hypothesis to be
addressed is that Plg-RKT promotes healthy adipocyte function and maintains systemic metabolic homeostasis
by coordinately regulating adipogenesis, insulin signaling, inflammation and fibrosis. To test our hypothesis our
specific aims are: 1) To elucidate the role of Plg-RKT in adipogenesis; 2) To determine the role of Plg-RKT in
regulation of insulin sensitivity; 3) To determine mechanisms by which Plg-RKT inhibits fibrosis and
inflammation in obesity; and 4) To perform preclinical studies to test the effects of over-expression of Plg-RKT in
vivo. We will employ a diet induced obesity model in mice with global and tissue specific (adipose and
macrophage) deletion of Plg-RKT, mice with global and tissue specific overexpression of Plg-RKT, and mice
doubly deficient for Plg-RKT and fibrinogen. Innovation lies in the investigation of a novel plasminogen receptor
as a crucial focal point for regulation of multiple key aspects of adipose function. The studies proposed are
significant because new knowledge of mechanisms by which adipose function and systemic metabolic
homeostasis are maintained will be acquired, with translational potential for drug development.

Public health relevance
Project Narrative Adipose dysfunction is a major contributor to obesity-mediated metabolic disorders including insulin resistance, diabetes and cardiovascular disease. The proposed research is relevant to public health because we expect to identify novel mechanisms that promote healthy adipose function and metabolic homeostasis, which may lead to development of therapies to treat and/or prevent the adverse metabolic and cardiovascular consequences associated with obesity.